Role of glycosylated RNAs in Acute Myeloid Leukemia

Project Summary/Abstract
Acute myeloid leukemia (AML) is a malignant blood disorder characterized by the accumulation of immature
myeloid progenitors at the expense of differentiated progeny. Despite the genetic heterogeneity of AML and
clinical treatments, there persists a common focus on enhancing clinical outcomes and in comprehending the
signaling mechanisms that allow for AML maintenance. The recent discovery glycosylated RNAs (glycoRNAs),
RNA molecules post-transcriptionally modified with sialylated-N glycans, has upended our traditional
understanding of RNA biology. Collaborator data has demonstrated cell surface glycoRNAs can serve as a
signaling mechanism between myelomonocytic cell types. Given this information, the goal for this proposal is to
characterize and define the role of glycoRNAs in acute myeloid leukemia. The first aim will characterize
glycoRNA expression and sequences in distinct AML subtypes with those from normal myeloid progenitors. The
second aim will define the role of Sidt proteins in AML glycoRNA expression and the third aim will determine the
functions of glycoRNAs in AML biology as it pertains to AML development in vivo, regulating leukemic cell
homing, and migratory capacity. Successful execution of these aims will provide valuable insight on the
expression, regulatory mechanism, and function of glycoRNAs in AML. Completion of this work will provide
significant advancements, potentially leading to novel clinical therapies for AML.

Public health relevance
Project Narrative Acute myeloid leukemia (AML) is a devastating blood disorder that presents a significant therapeutic challenge. This project aims to address the contribution of glycosylated RNAs (glycoRNAs) in AML maintenance. Understanding the role of glycoRNAs in AML will provide new mechanistic insights for improved therapeutic strategies.